A data resource for studying DNA methylation in diverse human tissue types

ABSTRACT
Epigenetic modifications of DNA, including DNA methylation (DNAm), play a central role in determining cell
identity and function, and epigenetic perturbations contribute to aging and disease. Characterizing variability in
human epigenomes and the causes of such perturbations is critical for understanding disease mechanisms.
“Epigenome-wide” studies of DNAm have demonstrated that effects of genetic variants on DNAm are
pervasive in the human genome (i.e., methylation quantitative trait loci, mQTLs), suggesting epigenetic
mechanisms of disease susceptibility. These studies have also identified loci where DNAm is associated with
age, exposures, and disease, enabling the development of “epigenetic clock” algorithms, exposure signatures,
and potential biomarkers of disease. However, these prior studies have (1) focused on a limited number of
tissue/cell types and (2) captured a small fraction of the ~28 million CpGs in the human genome. Thus, we
currently lack a truly whole-genome resource to study DNAm in large numbers of non-blood human tissue
samples. Large studies of DNAm in diverse tissue types are needed to improve our understanding of variability
in human epigenomes and its determinants. In response to this need, we propose to create a multi-tissue
DNAm data resource using samples obtained from tissue donors by the Genotype-Tissue Expression (GTEx)
Project. The GTEx data resource currently provides genome-wide data on genetic variation and gene
expression for >15,000 tissue samples from >900 donors (>50 tissue types), data which has provided an
unprecedented view of tissue-specific gene expression and regulation in humans. Complementary data on
DNAm would provide an integrated view of genetic effects on both transcription (eQTLs) and the epigenetic
background on which transcription occurs (mQTLs). A multi-tissue DNAm data resource would also support
many research questions that rely on comparable DNAm data across tissue types, including research on
aging, environmental epigenetics, and genome structure and function. Our first aim is to provide genome-wide
data on DNAm for ~2,100 GTEx tissue samples (~210 samples for each of 10 unique tissue types) to the
scientific community, using whole-genome bisulfite sequencing. Our second aim is to create and disseminate
a comprehensive catalog of genetic effects on DNAm in human tissues (mQTLs). We will present these
results on the GTEx portal, leveraging existing data visualization tools. Our third aim is to promote the use of
this DNAm data resource. We will provide online tutorials on data access and GTEx portal features, host
workshops at scientific meetings that will train data users, monitor use of the resource, and respond to the
needs of data users. The unique multi-tissue DNAm data resource we propose to create will be of broad
interest to the genomics community and relevant to many diseases of public health importance. We anticipate
this resource will be highly complementary to existing GTEx data and will greatly enhance the long-term impact
of the GTEx project on biomedical science and human health.

Public health relevance
NARRATIVE Epigenetic modifications to DNA, including DNA methylation, play a critical role in gene regulation, aging, and disease in humans, but variability in DNA methylation and its determinants have not been thoroughly characterized in most human tissue types. We will create a large, multi-tissue DNA methylation data resource using 2,100 samples from 10 diverse human tissue types, collected by the Genotype-Tissue Expression (GTEx) Project, and we will integrate this data with the existing GTEx data to identify genetic determinants of DNA methylation. We will share all data and results with the broad scientific community through regular data- releases and user-friendly data visualization tools developed by the GTEx portal, with supporting tutorials, workshops, and resource monitoring, thereby enhancing the long-term impact of the GTEx project on biomedical science and human health.